Epigenetic regulation in therapeutic human pancreatic beta cell proliferation

Project Summary
This is a K-01 application for Esra Karakose, PhD. Her overarching goal is discovering novel therapeutic
approaches for diabetes. This proposal investigates the role of epigenetics in the control of human beta cell
replication, aiming to identify novel pathways and drug targets that will enable human beta cell regeneration.
Candidate. Dr. Karakose is a junior faculty member (Instructor) at the Diabetes Obesity and Metabolism Institute
at Icahn School of Medicine at Mount Sinai. She holds a M.Sc degree from Bilkent University, Turkey, and a
Ph.D degree from the prestigious Max Planck Institute for Biochemistry, Germany. Her extensive experience in
molecular biology and genetics as well as the expertise she developed in beta cell biology during her postdoctoral
work have prepared her to successfully accomplish the objectives of this proposal. Her career development plan
includes four training goals all which will be instrumental to help her transition into an independent research
career: 1) Acquire advanced programming skills to better analyze and interpret data; 2) Gain hands-on
experience in single cell RNA-seq experiments and data analysis; 3) Develop Chromatin Conformation Capture
experiments and apply bioinformatics analysis; and, 4) Develop writing and leadership skills.
Mentors/Environment. Dr. Karakose will be mentored by her primary mentor, Dr. Andrew Stewart, and two
additional very accomplished and complimentary scientists. Dr. Martin Walsh is a prominent scientist in genetics,
epigenetics and pharmacology, and Dr. Sebra is a pioneer in next-gen sequencing technologies and analysis.
Mount Sinai provides state-of-the-art lab facilities as well as a highly dynamic scientific environment, thereby
creating an excellent opportunity for Dr. Karakose to thrive as a researcher.
Research. Current approaches to reverse beta cell loss in diabetes are limited: islet transplantation, whole
pancreas transplantation and stem cell-based strategies for transplantable beta cells. However, many hurdles
are associated with these approaches, including an insufficient number of organ donors, immune rejection, lack
of successful implementation in the case of stem cell-based strategies, and excessive cost. A promising
alternative is beta cell regenerative drug therapies. This proposal will be key to understand the mechanisms of
actions of the current beta cell regenerative drugs, all of which work through mechanisms involving beta cell
epigenetics. Moreover, it will provide crucial information for identifying novel drug targets for beta cell
proliferation. Aim 1 will define the open chromatin regions and histone mark signatures in of human pancreatic
beta cells treated with regenerative drugs. Aim 2 will determine epigenetic properties of proliferating beta cells
with single cell approaches. More specifically, Aim 2a will define the transcriptomes of the subset of human
pancreatic beta cell populations with the proliferative capacity, whereas Aim 2b will define 3D chromatin
architecture in proliferating human pancreatic beta cells.

Public health relevance
Project Narrative Diabetes is a chronic disease that results from deficiency of functional insulin-producing beta cells in the pancreas. One promising therapeutic approach to restoring beta cell mass is their expansion through regeneration of residual pancreatic beta cells. This Career Development proposal uses advanced genetic and epigenetic approaches in order to shed light on the fundamental mechanisms of action of the existing beta cell regenerative drugs, as well as to identify novel drug targets for diabetes therapy, and to provide essential and high-quality additional training to the applicant.